NIAID specific Pathogen-free non-human primate breeding colonies

The objective of this contract is to continue to operate and maintain a non-human primate (NHP) breeding colony to support the NHP Primate Transplantation Tolerance Cooperative Study Group (NHPCSG).